Gamma delta T cell based melanoma therapies

SUMMARY
Our long-term objective is to develop highly translatable animal models for testing cancer
immunotherapies. Animal models have been essential in cancer research. However, mouse tumor
transplantation or tumor genetic models lack critical components for studying human anti-tumor
responses such as high mutational load, tumor microenvironment (TME) and tumor heterogeneity or
mice have major differences from humans in innate and adaptive immune responses. In response to
PAR-20-131, we will use our novel humanized mouse models (HuMice) to test gamma-delta T (γδT) cell-
based immunotherapies. Since Vγ9Vδ2+ T cells, a subtype of γδT cells that are most commonly used in
adoptive immunotherapy, are unique to primates, traditional mouse models are not ideal to study human
γδT cells. This proposal will maximize translational potential of mammalian models by studying
Vγ9Vδ2+ T cells-based therapy in HuMice with HLA-matched human melanomas from cell lines or
patient-derived xenografts (PDX). Our laboratories have established >500 melanoma PDX and >300
melanoma cell lines, which represent all clinical, genetic and biologic groups of the disease. In Aim 1, we
will study adoptive transfer of enhanced γδT cells. We will test a new Vγ9Vδ2+ T cell expansion method
in HuMice. We will then equip γδT cells with DR5-CAR that targets both myeloid derived suppressive
cells and melanoma cells. We will study alterations in the TME after treatment. To avoid potential toxicity
of targeting DR5, we will develop a novel combinatorial CAR that targets PD-L1 and DR5. In Aim 2, we
will stimulate endogenous γδT cells for cancer therapy. We will use bromohydrin pyrophosphate (BrHPP)
and resiquimod to expand endogenous human γδT cells to treat melanoma bearing HuMice. We will
study whether BTN3A1 mAbs expand human γδT cells and govern antitumor functions of both γδ and
CD8+ T cells in HuMice. We will then combine expansion of endogenous γδT cells with anti-PD-1 mAbs
in melanoma-bearing HuMice. We expect that HuMice will allow us to test expansion of endogenous
Vγ9Vδ2+ for cancer therapy for the first time in a model system and our new expansion methods are
effective and may be optimized and tested in future clinical trials.

Public health relevance
NARRATIVE This project leverages our humanized mouse models to achieve two goals: 1) Determine treatment efficacy of adoptive γδT cell transfer for melanoma. 2) Stimulate endogenous γδT cells for melanoma therapy. We expect that HuMice will allow us to test Vγ9Vδ2+ T cells-based cancer therapy for the first time in a suitable model system and our new therapies are effective and may be optimized and tested in future clinical trials.